Studying temporal dynamics and regulatory mechanisms of single cells with a unified framework and multi-omics data

Single cell genomics technologies have allowed researchers to study differences between single cells. In order
to understand how every cell functions in the whole living organism, cells need to be studied in the context of
both time and space. Researchers would like to learn a comprehensive picture of each single cell, including its
current cell state and predicted future state, and how it interacts with neighboring cells during the temporal
dynamics. So the step after gaining a certain amount of knowledge of single cells is to go from “parts” to
“whole”. This proposal discusses advances that can be brought to the study of both temporal dynamics
and spatial interactions between cells. The theme of this proposal is “integration”.
Existing integrative methods for single cell data focus on two scenarios: 1) integrate the same type of data (eg.
RNA-Seq data) from multiple batches; 2) integrate multiple types of data performed on the same cells, which is
also called multi-modality data or multi-omics data. This proposal highlights concepts and methods to
integrate multi-omics data to understand cell temporal dynamics and regulatory mechanisms, while
taking into account dependency between data modalities, which is rare in current methods. A new
concept of “problem integration”, where related computational formulations can be connected to
provide a consistent and more general picture of a certain aspect of cells, is also presented here.
In order to study different aspects of a cell, different computational problems have been formulated, eg.,
clustering of cells, inference of cell trajectories, inference of gene regulatory networks (GRNs), etc. The idea of
unifying or connecting related computational problems, such that a unified framework can involve or
output the information that is previously used in multiple individual computational problems, is proposed. In
particular, a unified framework for cell temporal dynamics analysis involving related computational
tasks, is presented.
So far the multi-omics integration methods often deploy the integrated data to cluster cells for cell type
identification. Few methods on data integration are designed for temporal analysis with continuous populations,
or to learn biological mechanisms like GRNs. So another direction proposed here is to infer the trajectory of
cells with both gene-expression (scRNA-seq) and chromatin accessibility (scATAC-seq) data; with the inferred
trajectory, the effect of chromatin accessibility on gene-expression can be studied, and GRNs can be
reconstructed while taking into account this effect.
In reality, a gene’s expression level is determined by multiple factors: its transcription factor (TF), its chromatin
accessibility and the signal a cell receives from other neighboring cells through cell-cell interaction. Therefore,
another important dimension to consider about the cells is the spatial location of cells. It is proposed to
ßreconstruct a generalized GRN which models inter-cell regulatory interactions.

Public health relevance
Project Narrative High-throughput single cell genomics and transcriptomics technologies have allowed researchers to study our cells with unprecedented resolution and scale. With the knowledge obtained on individual aspects of cells and the development of technologies that can jointly profile multi-modality data, we are entering an era of “putting the pieces together”. In this proposal, we propose concepts and methods to integrate multi-omics data to understand cell temporal dynamics and regulatory mechanisms, and we also propose a new concept of “problem integration”, where related computational formulations can be connected into one unified framework to provide a consistent and more general picture of a certain aspect of cells.